Addressing racial/ethnic geographic disparities in COVID-19 health services and outcomes among nursing home residents with ADRD

PROJECT SUMMARY
Racial/ethnic health disparities exist for a wide array of nursing home (NH) services and health outcomes. These
disparities directly impact the care received by older adults in NHs. Alzheimer's Disease and Related Dementias
(ADRD) serve as a “disparity multiplier,” in that Black and Hispanic NH residents have worse health outcomes
and these differences are more pronounced for residents with ADRD. The importance of the intersection and
severity of racial/ethnic health disparities and ADRD has been highlighted by the COVID-19 pandemic, which
has disproportionately impacted NH residents and those with ADRD. The pandemic has also revealed how
significantly these disparities may vary by geography. Despite the differences in COVID-19 outcomes by
race/ethnicity and geography, and the potential exacerbation of these disparities by ADRD status, little evidence
exists to reveal exactly how or to what extent race/ethnicity, geography, and ADRD status intersect to jointly
impact the health outcomes of older NH residents. Additionally, the optimal methods for estimating wide-ranging
health disparities between racially/ethnically diverse subpopulations of varying sizes and demographics across
geographic units remain unclear. The long-term objective of the proposed research is therefore to develop a
causal inference framework for studying racial/ethnic health disparities across different geographic units. Aim 1
will identify the most appropriate analytic approaches for quantifying racial/ethnic disparities across geographic
units by conducting a simulation study comparing several existing biostatistical methods. Aim 2 will leverage
these results to quantify health disparities in COVID-19 vaccine use and outcomes by racial/ethnic status, ADRD
status, and geography through the use of a first-of-its-kind database of electronic medical records linked to
Medicare claims data from approximately 10,000 US NHs. This research will provide some of the first empirical
evidence for policymakers and other stakeholders that can be used to improve health equity for COVID-19 and
other conditions. It will also establish unique methods that can be used broadly to conduct accurate, timely, and
relevant future studies of disparities among NH residents and other populations. These proposed studies will be
completed by the principal investigator with support from collaborators with deep expertise in advanced statistical
methods, health disparities, infectious disease epidemiology, geriatrics, and ADRD. The principal investigator is
supported by a collaborative and interdisciplinary research environment that includes the Center for Gerontology
and Health Care Research at the Brown University School of Public Health. The training activities detailed in this
application are focused on advancing quantitative computational skills and developing a deep contextual
knowledge of racial/ethnic health disparities and the care of older adults with ADRD; they will prepare the
principal investigator for a career as an independent epidemiologist and health services researcher.

Public health relevance
PROJECT NARRATIVE Racial/ethnic health disparities impact the care received by older adults residing in nursing homes, and Alzheimer's Disease and Related Dementias (ADRD) may serve as a “disparity multiplier” that makes disparities in health outcomes even more pronounced. The COVID-19 pandemic has disproportionately affected nursing home residents and those with ADRD, thereby highlighting the intersection and severity of racial/ethnic health disparities and ADRD as well as how significantly these disparities may vary geographically. The proposed research will quantify disparities in COVID-19 vaccine use and outcomes by race/ethnicity, ADRD, and geographic location of residence to produce policy-relevant evidence for COVID-19 management and to establish unique methods that can be applied to answer impactful future research questions.